Optimization of cannabidiol-based formulations in autism spectrum disorder

Project Summary
Phytocannabinoids represent a novel treatment strategy for numerous neurological conditions including autism
spectrum disorder (ASD). However, despite promising results, current pre-clinical and clinical approaches are
limited by the inclusion of the Δ9-THC which raises legal and safety concerns, especially when being used by
children and adolescents. Therefore, we seek to optimize non-Δ9-THC containing cannabis-based treatment
approaches by harnessing the phytochemical synergism that exists between the non-intoxicating
phytocannabinoid, cannabidiol (CBD) and cannabis-derived terpenes. Reduced GABAergic signaling is a
common underlying neurochemical signature of ASD, and we hypothesize that compositions that maximally
restore the brain’s excitatory:inhibitory balance through boosting GABA signaling will reduce ASD phenotypes
and provide developmental protection against abnormal brain development. To test this hypothesis, we
propose to empirically assess the therapeutic efficacy of CBD alone and in combination with common cannabis
terpenes on ASD-like phenotypes in the BTBR mouse model of ASD using electrophysiological (Aim 1),
behavioral (Aim 2), and molecular techniques (Aim 3). In Aim 1, we will use local field potential and whole-cell
patch-clamp slice-electrophysiology approaches as a screening platform for identifying CBD+terpene
compositions that restore the excitatory:inhibitory balance and boost GABAA receptor mediated inhibition. In
Aim 2, we will test the therapeutic efficacy of these CBD+terpene compositions on social and motor symptoms
acutely in adulthood and separately following repeated exposure during a sensitive developmental window. In
Aim 3, we will assess molecular markers of efficacy and safety from a subset of subjects undergoing
developmental exposure to CBD and terpene compositions in Aim 2. We will measure critical drivers of
synapse stabilization and plasticity using Westen Blot protein analysis to identify developmental shifts in brain
derived neurotrophic factor and two-dimensional MALDI-TOF mass spectrometry to measure shifts in
endocannabinoid expression (i.e., 2-AG and anandamide).Together, these experiments will provide the most
comprehensive assessment of the proposed synergistic interactions between CBD and terpenes in a disease
model to-date, reveal optimized non-Δ9-THC cannabis-based treatment approaches for ASD, and provide
impactful undergraduate research experiences across numerous technical approaches in neuroscience.

Public health relevance
Project Narrative Cannabis-inspired terpenes represent a novel pharmacological strategy for phytocannabinioid synergism in medicine. We propose to identify safe and effective, non-Δ9-THC-containing, cannabidiol and terpene combinations in a mouse model of autism spectrum disorder using behavioral, electrophysiological, and molecular approaches. These experiments will yield optimized formulations that overcome current dose- response limitations, safety concerns, and reliability challenges observed with current phytocannabinoid-centric treatment options.